Exploration of the role of CART/GPR160 in metabolism in the setting of Magel2 deficiency: Implications for Prader Willi Syndrome

PROJECT SUMMARY
Severe hyperphagia is a hallmark of Prader Willi Syndrome (PWS). Multiple neuronal circuits have been
implicated in PWS-associated hyperphagia; however the complexity of the neural regulation of appetite has
obfuscated the precise mechanisms underlying the dysregulation of feeding circuits in the setting of PWS. The
neuropeptide cocaine and amphetamine regulated transcript (CART) is a key regulator of appetite and weight.
Central infusion of CART decreased food intake and weight gain in obese rats, and global deletion of CART in
mice led to predisposition to obesity and enhanced susceptibility to high fat diet-induced metabolic dysfunction.
Likewise, mutations in the CART gene have been linked to obesity in humans. Interestingly, hypothalamic levels
of CART peptide were reduced in an animal model of PWS. In spite of a wealth of evidence indicating an
important role of CART in metabolism, the ability of CART to reduce food intake in models of PWS has not been
reported. This lack of knowledge represents a major gap in the PWS field. Importantly, we recently identified the
cognate receptor of CART as the G protein coupled receptor, GPR160, thus enabling chemical biology methods
to design CART agonists for the treatment of PWS-associated hyperphagia. We hypothesize that central
injection of CART will reduce food intake in the setting of paternally-inherited Magel2 deficiency, and that Magel2
deficiency will lead to reduced expression of CART in central feeding centers, particularly the hypothalamus. We
will address our hypothesis in two Specific Aims. In Aim 1, we will inject CART icv into Magel2-deficient rats, and
food and water intakes and meal patterning will be measured using our BioDAQ system. Rats will then be placed
in an open field behavioral test to ensure that any observed effect of CART on food intake is due to a primary
effect of CART on appetite, rather than a secondary effect on locomotor behavior. Although proCART mRNA
levels likely are not modulated in PWS, the prohormone convertase responsible for the production of mature
CART, PSCK1, has been shown to be reduced in individuals with PWS, which leads to reductions in the
production of mature CART peptide. In Aim 2, we therefore will measure CART, GPR160, and PSCK1 levels in
brains, CSF, and plasma of Magel2-deficient rats compared to WT rats. Because CART peptide levels fluctuate
with metabolic state (i.e. reduced during fasting, normalized after re-feeding), we will determine if functional
changes in CART peptide levels occur in the setting of Magel2 deficiency using global proteomic analyses.
Lastly, we will determine if there are changes in the expression patterns of CART and GPR160 in the brains of
Magel2-deficient rats compared to WT rats. If our hypotheses are correct, then replacement with CART agonists
should at least partially control appetite in individuals with PWS. This strategy of targeting a system that is
parallel to, and not dependent upon, other feeding circuits could revolutionize treatment of PWS-associated
hyperphagia and offer an innovative solution to the severe obesity experienced by patients with PWS.

Public health relevance
PROJECT NARRATIVE Prader Willi Syndrome is a rare genetic disease that leads to extreme, unrelenting hunger, and resultant obesity. The goal of this proposal is to evaluate the ability of a molecule called CART to regulate appetite in a rodent model of Prader Willi Syndrome. Through these studies, we hope to identify CART as a potential therapeutic target for the treatment of Prader Willi Syndrome.